Extracorporeal Filtration of Thermosensitive Liposomes

PROJECT SUMMARY/ABSTRACT
This project will develop a device and perform proof-of-concept studies in a rodent tumor model. The device will
remove the chemotherapy agent Doxorubicin from systemic circulation after targeted delivery to tumors.
Targeted delivery occurs by temperature sensitive liposomes delivering Doxorubicin to tumor regions. By
exposing tumors to hyperthermia (40-42 ºC), drug is locally released and taken up by tumors at high dose.
Following hyperthermia, any remaining drug would result in toxicity to non-targeted tissue, and is removed by
the proposed extracorporeal filter device with real-time quantification of removed drug amount. If successful, this
would represent a novel approach to reduce dose-limiting toxicities, allowing delivery of higher chemotherapy
dose and/or reducing toxicity related side effects.

Public health relevance
PROJECT NARRATIVE – RELEVANCE TO PUBLIC HEALTH This project will develop technology that removes chemotherapy from the blood stream that has not been delivered to cancerous tumors. Thereby, toxic side effects of chemotherapy are reduced, and therapy efficacy can be enhanced since larger drug dose can be administered and delivered to tumors.